A Phase II Trial to Prevent Linear Growth Stunting and Malnutrition in Impoverished Children from a Low-Income Country by Treating Small Intestine Bacterial Overgrowth

PROJECT SUMMARY/ABSTRACT
Stunting affects 23.8% of children under age 5 and is associated with poor neurodevelopment and early
death. Small intestine bacterial overgrowth (SIBO) in impoverished children living in unsanitary
environments in low-income countries is associated with intestinal inflammation and stunting. This project
will build upon our preliminary data showing that SIBO predicts future stunting. Our objectives are to
determine if treating SIBO in Bangladeshi infants under ideal conditions (i.e. frequent screening and
treatment of all episodes) improves growth and to determine the structure and function of the enteric
dysbiosis that children with SIBO have. Further, we will determine how this aberrant microbiome affects
human metabolism to cause stunting and malnutrition. To this end, we have 3 aims. Aim 1 is to conduct a
Phase IIa trial to determine the optimal antibiotic regimen to treat SIBO in Bangladeshi toddlers. In this
treatment optimization trial, we will test three antibiotic regimens (amoxicillin-clavulanate, metronidazole,
and trimethoprim-sulfamethoxazole + metronidazole) given for 14 days for their efficacy in reversing a
positive glucose-hydrogen breath test, the most commonly used SIBO diagnostic. Aim 2 is a treatment
efficacy study in which we will conduct an assessor blinded passively controlled Phase IIb trial to test if a
package intervention of frequent SIBO testing and treatment of all positive tests improves growth and enteric
inflammation over the first 18 months of life. Children will be enrolled at birth and randomized to an active
or control arm. All children will be breath tested for SIBO every 6 weeks. Children in the active arm will
receive the optimal antibiotic regimen chosen in the Phase IIa trial for 14 days in response to each positive
test. Children in the control arm will not be treated. Our primary outcome is length-for-age Z score at 18
months. Aim 3 will define the relationship between the enteric lactate-H2-butyrate economy seen in SIBO
and host metabolism. Preliminary data indicates that a positive breath test is associated with increased
enteric Lactobacillus species (lactate producers), decreased butyrate producers, and an excess of enteric
hydrogen. However, the details of the interactions between these commensal populations are poorly
understood. We will conduct two sets of comparisons between 1) SIBO positive and SIBO negative children
and; 2) between SIBO positive children before and after treatment, all enrolled in the Phase IIb trial. We will
compare fecal metagenomics and metatranscriptomics as well as serum metabolomics to understand the
structure and function of the SIBO dysbiosis and how it leads to alterations in growth and development. This
work seeks to utilize a novel treatment strategy for malnutrition by targeting antimicrobial therapy only to the
subset of malnourished children with SIBO. It also seeks to further our understanding of the mechanisms by
which the SIBO microbiome influences growth and development.

Public health relevance
PROJECT NARRATIVE Successful completion of the proposed aims will determine the optimal treatment regimen for small intestine bacterial overgrowth (SIBO) in impoverished children from low-income countries and test if a package intervention of frequent SIBO screening and subsequent treatment of positive tests improves linear growth and decreases enteric inflammation in the 10-30% of malnourished children with the condition. We will also utilize a multi-omics approach to significantly further our understanding of the structure and function of the intestinal microbiota that SIBO represents and how this dysbiosis impacts child growth and development. These aims seek to lay the groundwork for targeted SIBO therapy in the treatment of malnutrition and abrogate its effects in the 23.8% of children worldwide under the age of 5 years who are growth stunted.